Technology Operations Core

Project Summary/Abstract The Technology Operations Core (TOC) will enable user access to biological soft x-ray tomography at the ALS and be responsible for the day-to-day user operation of the Resource. In particular, the TOC will maintain and calibrate XM-2, the Resource operated soft x-ray microscope at the ALS. The TOC will also be responsible for maintaining and upgrading ancillary instruments and software to keep the Resource operating at the “state-of-the-art.” This core will ensure soft x-ray tomography is readily accessible to the biomedical community, and users get the best possible soft x-ray tomographic data from their specimens.